Neurovascular Mechanisms Underlying the Negative Effect of Stress in Cognitive Aging

Stress increase risk for cognitive decline among older Veterans, but the mechanistic link between
stress and cognitive aging remains poorly understood. Further, currently existing stress-related interventions
are generally aimed at preventing stress-related emotional and physiological changes, and have shown very
limited utility in mitigating cognitive symptoms. Identification of the neurobiological mechanisms underlying
stress-related cognitive change, particularly those that are modifiable in nature, would have enormous
implications for intervention strategies. In this context, several potentially modifiable biological systems have
been implicated as mediators of the relationship between perceived stress and cognitive aging and hold great
promise as treatment targets, including neurovascular function. Importantly, there appear to be multiple stress-
related pathways that have negative downstream effects on the cerebral endothelium, or the inner cellular
lining of blood vessels. In turn, endothelial dysfunction is thought to disrupt blood brain barrier integrity and
cerebral blood flow (CBF), neurovascular processes critical to the maintenance of cognitive function and brain
health. Given the evidence implicating CBF and endothelial dysfunction in the pathophysiology of stress-
related cognitive impairment, combined with evidence that these processes can be successfully modified by
behavioral (e.g., physical activity) and pharmaceutical interventions, it is surprising that no study, to our
knowledge, has directly explored CBF and endothelial dysfunction as mediators of the relationship between
stress and cognitive impairment. The current proposed career development award (CDA) aims to bridge this
gap by utilizing a multimodal and transdiagnostic approach to examine relationships among a robust and
comprehensive measure of self-reported stress, arterial spin labeling (ASL) MRI-measured CBF, blood-based
biomarkers of endothelial dysfunction, and cognitive performance among a sample of 100 older adult (65+)
trauma-exposed Veterans. Participants will undergo an MRI scan, a blood draw, a clinical interview, and a
neuropsychological battery. Multiple regression and serial mediation analyses will be utilized to determine
relationships among lifetime stress severity, serum vascular adhesion molecule-1 (sVCAM-1) levels, medial
temporal lobe (MTL) and medial prefrontal cortex (mPFC) CBF, and cognitive performance (memory, executive
functioning). The primary goal of the study will be to test the hypothesis that the neurovascular dysfunction
accounts for relationships among the subjective experience of stress and cognition. Results will improve
understanding of the role of stress in cognitive aging. Moreover, this study represents the critical first step
toward identifying modifiable biomarkers that can serve as treatment targets for interventions aimed at
mitigating currently existing stress-related damage to brain and cognitive health among older Veterans.
Building upon the applicant’s prior experience in neuroimaging and cognitive aging, the proposed CDA also
provides opportunity for new hands-on training in stress-related research methodologies, blood-based
biomarkers, vascular function, and advanced statistical analysis. This dovetails with the candidate’s long-term
career goal of developing expertise at the intersection of stress and cognitive aging. Data from this project will
provide critical pilot data for successful preparation of a VA Merit Award. Together, this research and training
plan will well position the applicant for transition to an independent clinical researcher within the VA system.

Public health relevance
The proposed CDA-2 will provide Dr. Hays with the training, expertise and research support to examine the extent to which neuroimaging and blood-based biomarkers of neurovascular function (i.e., cerebral blood flow, endothelial dysfunction) account for the negative impact of lifetime stress severity on cognition. This project aims to leverage an innovative multimodal and transdiagnostic approach in order to improve understanding of stress-related cognitive aging and identify modifiable biomarkers that can serve as treatment targets for interventions aimed at preventing or mitigating currently existing stress-related damage to brain and cognitive health. These aims are well aligned with the primary mission of the VA to improve patient care for Veterans and to more specific missions and core values of the VA related to clinical research and geriatrics.